AIDS CLINICAL TRIALS--A DECISION-MAKING KIT FOR PARENTS

DESCRIPTION: (Adapted From The Investigator's Abstract) This Phase I project proposes to produce a preliminary version of a videotape that will inform parents about clinical trial opportunities and will help them to evaluate the appropriateness of enrolling their HIV infected child. The investigators have assembled a team of video and HIV experts to produce the preliminary version of the videotape and conduct three focus groups to test its effectiveness with a target audience of minority and urban parents.It is proposed, in Phase II, to refine and complete the video and produce an accompanying brochure. The market will be clinical trial locations and pharmaceutical manufacturers.